Career Enhancement Program (CEP)

PROJECT SUMMARY
The goal of the Leukemia SPORE Career Enhancement Program (CEP) is to recruit and support new
independent investigators in the field of translational leukemia research. To accomplish this objective, the CEP
program will provide financial support, didactic training and mentored research training. The CEP will leverage
Institutional strengths to recruit basic scientists and clinical investigators from varied disciplines to promote
multidisciplinary translational research and will extend current efforts to promote diversity through the recruitment
of women, minority and disabled faculty. To the following specific aims are proposed: 1. To recruit and support
new investigators in the field of translational leukemia research. A total of $300,000 has been committed annually
to support the combined CEP and DRP. We will fund CEP awardees annually at $60,000 per year. The awardees
will either be junior faculty who are just beginning their research careers, or established researchers who are
transitioning into the field of translational leukemia research. 2. To provide training and mentoring to junior faculty
in translational leukemia research. CEP awardees will be mentored by a senior basic science and clinical mentor.
In addition to mentored research training, CEP will work with new investigators to craft an individualized career
development plan which may combine didactic coursework, patient care, and career skills tailored to their
individual goals. 3. To foster inter-SPORE collaborations. We have established educational exchanges with our
peer SPORE institutions to provide CEP awardees the opportunity to present their research and meet with the
leadership at a peer Leukemia SPORE Institution 4. To promote participation of women, minorities, and disabled
investigators in leukemia research. Dr. Cherilynn Shadding, Director of Outreach for the McDonnell Genome
Institute at Washington University will assist with the recruitment, training, and retention of women, minority, and
disabled investigators in leukemia research at all levels of training.

Public health relevance
PROJECT NARRATIVE Continued improvement in outcomes for leukemia patients requires the recruit and support of new independent investigators in the field of translational leukemia research. To accomplish this objective, the Career Enhancement Program will provide financial support, didactic training and mentored research training to promote multidisciplinary translational research and promote diversity through the recruitment of women, minority and disabled faculty.